Mechanisms of DNA damage processing and the initiation of Nucleotide Excision Repair

Project Summary:
Mechanisms of DNA damage processing and the initiation of Nucleotide Excision Repair
The goal of this research is to determine the structural mechanism of nucleotide excision repair
(NER) initiation. NER is the most versatile DNA repair mechanism that repairs a wide variety of
DNA lesions through a multistep process involving over 30 different proteins. Being essential to
maintaining genome integrity, this pathway is also highly conserved from yeast to humans.
Genetic defects in NER factors lead to phenotypes ranging from extreme cancer predisposition
syndrome (xeroderma pigmentosum) to severe neurodevelopmental defects (Cockayne
syndrome), thus providing a unique paradigm to understand diverse clinical outcomes of DNA
damage. Recent studies also revealed NER as a major contributor of somatic mutation hotspots
in various sporadic cancers and NER has been suggested as an attractive target for anti-cancer
therapy.
Despite its biological and medical importance, delineating the mechanisms of NER has been a
long-term challenge due to the complex compositions and functions of NER factors and the lack
of comprehensive structural understanding of their interplay on DNA. This proposal aims to define
the mechanism of NER initiation in detailed 3D structures using cryo-EM combined with time-
resolved fluorescence spectroscopy and crosslinking/mass-spectrometry. The outcome will
answer fundamental questions regarding (1) how the two key NER initiators, Rad4-Rad23-Rad33
(yeast homolog of XPC-RAD23B-CETN2) and TFIIH, together start the DNA ‘opening’ around the
damage - a critical step in NER initiation, and (2) how the torsional stress in DNA impacts this
process. This understanding will provide the foundation to explain various pathophysiologies
involving NER, which in turn can lead to novel strategies to counter various NER-linked diseases
including cancer.
Importantly, our research will provide solid training grounds for several undergraduate
researchers every year and will significantly enhance the biomedical research environment at
Baylor University, an undergraduate-focused institution, through its intimate collaboration with
UPenn Medical School. Immersed in an interdisciplinary research project with access to cutting-
edge technologies, our undergraduate researchers will gain expertise in various biochemical and
biophysical approaches and grow as key drivers of significant science.

Public health relevance
Project Narrative: Mechanisms of DNA damage processing and the initiation of Nucleotide Excision Repair Unrepaired DNA lesions interfere with normal cellular functions such as replication and transcription, often resulting in mutations and genome instability. Among the known repair mechanisms, nucleotide excision repair (NER) is the primary mechanism for clearing diverse helix-distorting DNA lesions including intrastrand crosslinks formed by UV light or anti-cancer drugs. Here, we will characterize the 3-D structural mechanism of NER initiation using several cutting-edge technologies (cryo-EM combined with time-resolved fluorescence spectroscopy and crosslinking/mass-spectrometry). The research will provide solid training grounds for several undergraduate researchers while also significantly enhancing the biomedical research environment at Baylor University through its close collaboration with the University of Pennsylvania medical school. The research outcome will provide a valuable foundation to delineate the diverse impacts of various pathological mutations, which may lead to novel strategies to modulate NER to counter various NER-related diseases.